Project 1: Precision targeting of therapeutic vulnerabilities specific to African American lymphoma patients

PROJECT 1_ Precision targeting of therapeutic vulnerabilities specific to African American
lymphoma patients: ABSTRACT
Diffuse large B cell lymphomas (DLBCLs) are highly heterogeneous, with many patients remaining incurable, and survivors often facing long-term medical and financial challenges. Patients of African Ancestry (AA) more commonly develop DLBCL at a younger age and have worse outcomes, but little is known about differences in disease biology. Our research found that AA DLBCLs exhibit a unique genetic profile, with mutations in SETD2, ATM, and MGA that impair DNA damage sensing and induce senescence. In AA-DLBCLs and mouse models, we identified an abundance of cells exhibiting the senescence-associated secretory phenotype (SASP), a feature linked to tumor initiation and immune evasion. SASP cells produce distinct cytokines such as IL-16, IL-10, and IL-20. We also observed that most AA-DLBCLs display an inflammatory lymphoma microenvironment (LME) with high levels of exhausted CD8+ T cells – features that predispose to immunotherapy resistance. We hypothesize that AA-DLBCLs represent a novel DLBCL subtype driven by genomic instability and the SASP phenotype, which promotes immune evasion through exacerbated inflammation, possibly driven by IL-16-mediated CD4+ T-cell recruitment and CD8+ T-cell exhaustion. Our proposal will (1) identify the mechanisms driving the SASP phenotype in AA-DLBCLs, (2) uncover how the LME of these tumors promotes immune evasion, and (3) determine the effect of anti-SASP drugs on enhancing immunotherapy and standard-of- care chemotherapy and preventing relapse of AA-DLBCLs.

Public health relevance
Diffuse large B cell lymphomas (DLBCLs) in patients of African Ancestry (AA) are associated with distinct genetic mutations (like SETD2) that impair DNA damage sensing and repair, leading to chemotherapy resistance and poor outcomes. Our research identified that these tumors exhibit a unique inflammatory microenvironment and are enriched with malignant cells presenting a senescence associated secretory phenotype (SASP) that drive immune evasion and tumor progression. Targeting the SASP phenotype with SETD2 inhibitors could improve immune responses and enhance the effectiveness of existing therapies, such as standard chemoimmunotherapy (i.e. RCHOP) and novel immunotherapy approaches.